Targeting Myosin to Treat Polycystic Kidney Disease

PROJECT SUMMARY
Polycystic kidney disease (PKD) is a major life-threatening, multi-organ disorder that affects 12M individuals,
representing a market opportunity of $1B. In PKD, tiny tubules in the kidneys, liver, and brain vasculature
expand into fluid-filled cysts. PKD is commonly inherited as a loss-of-function mutation in PC1 (polycystin-1) or
PC2, but how this results in cysts remains incompletely understood. Tolvaptan, a vasopressin receptor
antagonist, is the only approved treatment, but side effects make it unsuitable for many patients. Thus a
compelling need and market exists for additional treatments and targets.
To better model PKD and develop therapeutic strategies, we have previously invented human organoids that
recapitulate PKD-specific cyst formation from kidney tubules. Our studies revealed that inhibitors of NMII
(non-muscle myosin II), an ATP-driven motor that regulates stiffness and contractility, increase cystogenesis in
PKD organoids. Similarly, genetic NMII deficiency causes kidney cysts in mice in vivo. Conversely, we can now
show that NMII activators reduce PKD cyst growth, both in human organoids and mice. Such NMII activators
are first-in-class compounds, building on studies advancing cardiac myosin II activators into clinical trials. Our
Plurexa-UW team has furthermore blueprinted a pipeline of drug development in this area, from in silico all the
way to in vivo studies.
Based on our studies and the literature, we hypothesize that small molecule NMII activators induce
conformational changes in the NMII active site that increase ATPase activity and actinomyosin contractility in
PKD tubules, inhibiting their deformation into cysts.
The primary objective of this project is to sufficiently demonstrate and de-risk an NMII activator to justify
advancing it into IND-enabling studies for PKD, potentially in partnership with a pharmaceutical company. A
secondary goal is to advance our suite of tools in silico, in vitro and in vivo as a cohesive platform for drug
development and discovery in this arena. We will achieve the goals and prove the hypothesis with two aims:
Aim 1. Define the structure-activity relationship of NMII activators using a computational-biochemical
pipeline suitable for lead optimization.
Aim 2. Prepare NMII activators for IND-enabling studies by intervening with cyst formation in vitro and
in vivo.
These complementary Aims will be pursued in parallel to establish an optimally potent and selective NMII
activator across biological scales. We will confer with an expert advisory council to guide the work towards
establishing a basis for IND-enabling studies for these first-in-class compounds.

Public health relevance
PROJECT NARRATIVE Polycystic kidney disease (PKD), in which tiny tubes in kidneys and other organs expand into balloon-like cysts, affects 12,000,000 people, making it the most common genetic cause of kidney failure, with limited treatment options and no cure. Using human mini-kidney structures as well as mice with PKD, we have discovered that cyst formation can be blocked using small molecules previously developed to target specialized proteins called myosins, which shape and strengthen cells. The goal of this proposal is to connect the dots between these small molecules, a specific form of myosin found in kidney tubular epithelial cells, and the PKD cyst phenotype, to ready our small molecules and drug development pipeline for clinical trials.